Development of YK-4-250, a radiation mitigator of GI-ARS

ABSTRACT
Gastrointestinal (GI) toxicity remains a significant contributor to mortality following exposure to ionizing
radiation (IR), leading to GI Acute Radiation Syndrome (GI-ARS). Current lack of effective therapy for GI-ARS
underscores the critical need for medical countermeasures (MCM). This study aims to investigate the
mechanisms regulating the renin-angiotensin system (RAS) and reactive oxygen species (ROS) signalling
through the AT1 receptor to mitigate GI-ARS.
The research introduces a novel, selective and potent Tempol-ARB conjugate, YK-4-250, targeted to the AT1
receptor. Preliminary data show that oral administration of 20 mg/kg YK-4-250 at 24, 48 and 72 hours after
exposure to 14.3 Gy partial body irradiation (PBI) significantly mitigated GI-ARS in mice, leading to GI-recovery
by day 7 and an 88% overall 30-day survival.
The hypothesis postulates that IR activates RAS, elevating Ang II levels, causing oxidative damage and
triggering pro-inflammatory cytokine release, ultimately contributing to acute GI-ARS. YK-4-250 is proposed as
an effective radiation mitigator, with specific aims including assessing improved safety vehicle formulations,
measuring basic in vivo safety, defining pharmacokinetics, determining pharmacodynamics, and evaluating
survival efficacy in GI-ARS and pulmonary fibrosis models. Our final aim explores the concept that AT1R
knockout mimics YK-4-250 in mitigating GI injury and prolonging post-radiation survival. The study seeks to
perform formulation development for YK-4-250 for use in vivo studies, identify molecular mechanisms enhancing
cytoprotective function, and investigate its utility in mitigating IR-induced lung fibrosis. Successful completion of
these studies is anticipated to advance YK-4-250's development as a effective radiation mitigator for GI-ARS,
potentially expanding its application as a broader medical countermeasure.

Public health relevance
NARRATIVE Gastrointestinal Acute Radiation Syndrome (GI-ARS) results from exposure to a lethal dose of ionizing radiation, causing severe damage to the GI tract and, in some cases, acute death. This proposal aims to develop improved oral and cutaneous formulations for the oral radiation mitigator YK-4-250 and evaluate their efficacy in GI-ARS and radiation-induced lung models. Mechanistic studies will include the use of knockout animals lacking a crucial member of the renin-angiotensin system to assess underlying mechanisms, as the novel radiation mitigator targets and reduces harmful reactive oxygen species in the GI and lung cells.